LEARNING AND MEMORY IN SENSORY SYSTEMS

Funds are requested to support a symposium entitled "Learning and Memory in Vision", scheduled for June 8-11 at the University of Rochester. Recent experimental evidence of plasticity and learning in the adult visual cortex even at the earliest stages of processing suggests a need for the development of new approaches to the study of vision. One of the goals of the meeting is to bring together researchers whose work focuses on the plastic nature and dynamic representation of vision. Nineteen prominent scientists who approach the question of learning and memory in vision from the physiological, anatomical, behavioral and computational perspective will present 45 minute talks. Individual sessions will cover the following topics: cellular and anatomical foundations of learning and memory, adult cortical plasticity, perceptual learning, short-term memory: active observer, and visual short-term memory.